EFFECT OF FOSINOPRIL ON METABOLIC PROFILE OF PATIENTS WITH NEPHROTIC SYNDROME

This pilot study is designed to evaluate the effect of fosinopril on reducing the proteinuria, and improving the metabolic profile and nitrogen balance in patients with nephrotic syndrome.